Project 2

Abstract
We propose to investigate the role of neuromodulation in the phenomenon of “whole-cortex” activity of
the pial neurovascular circuit. This circuit is composed of a network of pial arterioles that integrate neuronal
activity with the intrinsic arteriolar vasomotion producing dynamic patterns of coherent oscillations in the
arteriolar diameter effectively parcellating the cortical mantle.
Prior research suggests that ascending neuromodulatory systems may work in parallel affecting the brain state
and processing capacity of large-scale cortical networks. In the majority of these studies, however, the
presence of neuromodulatory neurotransmitters in the cortex was not directly measured. Rather, their release
was inferred from stimulation of the corresponding subcortical nuclei or indirect measures. To overcome this
limitation, in the proposed project we will use direct, selective and sensitive optical probes for
acetylcholine, norepinephrine, dopamine and serotonin and track the presence of these neurotransmitters
in space and time across the cortical mantle in awake behaving mice. We will combine these probes with
optical imaging of neuronal Ca2+, blood oxygenation, optically transparent electrode arrays, optogenetic
manipulations and BOLD fMRI. Using these tools, including those pioneered by the members of our team, we
will address the role of neuromodulation in generation of (i) large-scale spontaneous cortical neuronal activity
observed with wide-field Ca2+ imaging, (ii) temporally coherent patterns of vasomotion in the pial neurovascular
circuit, and (iii) the resultant spatiotemporal pattern of hemodynamic fluctuations. Further, we ask whether
these spatiotemporal patterns of vasomotion and hemodynamics, which can be measured noninvasively, can
be used to infer the underlying internal brain state and/or activity of specific neuromodulatory systems.
We will collaborate with Project 1 to understand the rules of integration of the neuromodulatory drive with local
neuronal activity and intrinsic oscillatory dynamics within the pial neurovascular circuit. We will also collaborate
with Project 3 to ensure that our findings translate up the scale from mice to humans. A critical link to Project
3 will be simultaneous optical/fMRI studies in awake mice. Finally, we will work with Project 4 to devise a
phenomenological mathematical model that captures the essence of a brain state from the standpoint of the
vascular integrator producing large-scale patterns of coherent vascular/hemodynamic fluctuations.
This Project will provide a novel, unprecedented view on the role of neuromodulation in orchestrating large-
scale spontaneous neuronal and hemodynamic activity, explore the underlying mechanisms, and offer a strong
physiological foundation for the interpretation of large-scale fMRI signals and better understanding of the
mechanisms linking spontaneous neuronal activity to cognitive performance. In collaboration with other
Projects, we will deliver a predictive, conceptual model of local and global control of the pial
neurovascular circuit and inference of brain states and specific neuromodulatory circuits in humans.